Core A: Administrative Core

PROJECT SUMMARY
Administrative Core
The overarching goals of the Administrative Core of this Dana-Farber/Harvard Cancer Center (DF/HCC)
Ovarian Cancer SPORE application are to provide leadership and administrative oversight of the overall grant,
integration of the SPORE components as well as integration of the overall Ovarian Cancer SPORE within the
Dana-Farber/Harvard Cancer Center (DF/HCC), and promote and engage activities that allow the success of
the Ovarian Cancer SPORE Projects, Cores, the Developmental Research Program (DRP) and the Career
Enhancement Program (CEP). Drs. Matulonis, D’Andrea, and Spriggs will work within the multi-PI/PD
framework. The Leaders of this Ovarian Cancer SPORE grant, Drs. Matulonis, D’Andrea, and Spriggs, will
work directly with the DF/HCC SPORE Committee, the External Advisory Board (EAB), the Internal Advisory
Board (IAB), and the Ovarian Cancer SPORE Advocate Board to obtain recommendations and feedback and
implement them into the DF/HCC Ovarian Cancer SPORE components and the overall grant. The Overall
Directors of this SPORE grant, Drs. Matulonis, D’Andrea, and Spriggs, will equally closely monitor projects
throughout the entirety of the granting period and, in return, give constant and real time input; they will also
have the authority to alter funding based upon project performance, and they will do this collaboratively. The
structure of this SPORE grant will allow close supervision of all Projects and Cores and flexibility to allow
project revision based on oversight feedback and whether underperforming projects should be dropped
altogether or replaced. The SPORE PIs/PDs will ensure and facilitate interaction among the projects as well as
access to SPORE resources such as Cores. The DRP and CEP will function as a critical pipeline of
scientifically and clinically noteworthy projects and investigators that could be incorporated into the SPORE
based on the advice of the advisory boards (EAB and IAB) and the DRP and CEP leadership; Drs. Matulonis
and Spriggs will have direct oversight of the DRP and CEP.

Public health relevance
PROJECT NARRATIVE – Administrative Core The overarching goals of the Administrative Core of this Dana-Farber/Harvard Cancer Center (DF/HCC) Ovarian Cancer SPORE application are to provide leadership and administrative oversight of the overall SPORE grant, integration of the SPORE components and the overall Ovarian Cancer SPORE within the Dana- Farber/Harvard Cancer Center (DF/HCC), and promote and engage activities that allow the success of the Ovarian Cancer SPORE Projects, Cores, the Developmental Research Program (DRP) and the Career Enhancement Program (CEP).